AI-Enhanced and Culturally Adapted STAR-C for Latino Caregivers: A Stage I Pilot Study

PROJECT SUMMARY/ABSTRACT
Latino adults face a higher risk of Alzheimer’s disease and related dementias (ADRD) than non-Latino White
adults. The number of cases is expected to rise sharply in the coming decades, with Latinos facing the largest
increase among all racial and ethnic groups. This growth will intensify caregiving demands on Latino families,
who already face challenges managing behavioral and psychological symptoms of dementia (BPSD) and often
lack culturally appropriate professional support. STAR-C is an evidence-based behavioral intervention that
equips caregivers with strategies for managing BPSD. It was originally delivered in-person by a coach but was
later adapted to a virtual format with e-learning modules and phone check-ins with a coach. However, STAR-C
was not developed with consideration of Latino cultural values, beliefs, and practices. As a result, the content
lacks cultural and linguistic relevance for Latino caregivers. Latino caregivers’ engagement with the STAR-C
virtual intervention also remains underexplored since prior testing included mostly non-Latino White
participants. To enhance access for Latino caregivers, it is crucial to address cultural and linguistic relevance,
time constraints, and the need for personalized support. Artificial intelligence (AI) offers a promising solution by
providing culturally and linguistically tailored on-demand support. We propose to integrate an AI-driven virtual
assistant with chatbot functionality into STAR-C. This virtual assistant will provide real-time support between
coach check-ins and reminders to engage with e-learning modules that have been culturally adapted. This
Stage I study has three specific aims. Aim 1 is to develop and integrate an AI-driven virtual assistant in the
STAR-C intervention. We will follow our recent approach for creating a Large Language Model (LLM)-based
chatbot. We will refine the model with input from STAR-C coaches, selecting the best-performing version. We
will conduct usability testing with Latino caregivers to further optimize the virtual assistant based on their
feedback. Aim 2 is to evaluate fidelity and caregiver acceptance of the AI-enhanced STAR-C intervention. Fifty
Latino caregivers will participate in a 6-month intervention involving e-learning modules, phone check-ins with
a human STAR-C coach, and on-demand support from the virtual assistant. The study will assess fidelity of
intervention delivery and caregivers’ perceived usefulness, ease of use, behavioral intention, and actual use of
the intervention. Aim 3 is to assess Latino caregivers’ attitudes toward using the AI-enhanced STAR-C
intervention. Qualitative interviews with the 50 participants will assess their perceived benefits, challenges, and
emotional responses to the AI-enhanced STAR-C intervention. These qualitative findings will be integrated with
quantitative data from Aim 2 to provide a comprehensive understanding of Latino caregiver acceptability of the
AI-enhanced and culturally adapted STAR-C intervention. The findings of this Stage I study will lay the
groundwork for advancing along the NIH Stage Model to develop a scalable and effective intervention that
improves health outcomes for Latino caregivers and their family members with ADRD.

Public health relevance
PROJECT NARRATIVE Latino caregivers of people living with Alzheimer’s disease or related dementias (ADRD) have limited professional support for managing behavioral and psychological symptoms of dementia, placing them at a greater risk for adverse health outcomes. This project aims to develop a culturally adapted, AI-enhanced intervention to help Latino caregivers manage these symptoms in their family members. It will lay the groundwork for future research to expand access to culturally relevant training and support, ultimately benefiting the health and well-being of Latino families affected by ADRD.